Estimates of Populations of U.S. Counties

Purpose: a. Too develop July 1, 2000, 2001, 2002, 2003, 2004, 2005, 2006, 2007, 2008, 2009, 2010 and 2011 county-level population estimates by bridged race, Hispanic origin, and sex for single year ages 0-84 and age group 85+; b. To develop July 1, 2000, 2001, 2002, 2008, 2004, 2005, 2006, 2007, 2008, 2009, 2010 and 2011 county-level population estimates by bridged race, Hispanic origin, and sex for age categories 85-89, 90-94, 95-99, and 100+